CORE--DEVELOPMENT FUNDS

Description: During the current funding period, the initial allocation for Developmental Funds was $200,000 per year and the rating at the prior review was very good-excellent; the majority of support was allocated for new investigator development. The current application requests $550,000 per year to include $300,000 for new investigator development, $150,000 for pilot projects, and $100,000 for development of shared new resources. New processes for allocation of funds, and accountability are provided.